Mechanism of Altered Synaptic Signaling by Disease Related GRIN1 Variants

PROJECT SUMMARY / ABSTRACT
Variations in the GRIN1 gene result in neurological disorders with an incidence rate of 5.45 per 100,000 births.
Among these rare diseases, symptoms include epilepsy and seizures, intellectual disabilities and developmental
delays, and behavioral and movement disorders. The GRIN1 gene encodes the obligatory GluN1 subunit of N-
methyl-D-aspartate receptors (NMDARs), which are postsynaptic ligand-gated ion channels that are essential in
the standard development and operation of the central nervous system. Pathological variations in this gene often
occur in and around the critical activation gate of the receptor, which controls the opening and closing of the ion
channel pore. Of the many pathologic GRIN1 variations identified so far, only a handful have been functionally
characterized, and GRIN1-related disorders remain poorly understood. This project will delineate the activity,
gating mechanism, and potential pharmacological interventions of two pathological GluN1 variations at residue
647 (Y647C and Y647S). Patients with either of these variants exhibit severe cognitive developmental delay,
acquired microcephaly, extensive bilateral polymicrogyria, and seizure activity. The experiments proposed will
test the HYPOTHESIS that the GluN1 Y647C and Y647S variants impair receptor signaling by producing gating
deficits, which may be rescued with positive allosteric modulators. APPROACHES will include protein chemistry
and mutagenesis, molecular biology, and patch-clamp electrophysiology in cultured cells and mouse brain slices.
Aim 1 will characterize biophysical properties and disrupted inter-subunit contacts of recombinant NMDARs
containing the GluN1 Y647C and Y647S variants in human embryonic kidney (HEK293) cells. Aim 2 will examine
pharmacological rescue of these variants with positive allosteric modulators of NMDARs, GNE-9278 and GNE-
0723. Aim 3 will investigate how the GluN1 Y647S variant affects synaptic transmission in both excitatory and
inhibitory neurons and the effect of pharmacological interventions using brain slices from mice with the same
genotype as human patients (GRIN1+/Y647S). This project will RESULT in a comprehensive characterization of
two pathological GRIN1 variants and will provide a greater understanding of the disease mechanism in GRIN1-
related disorders. Additionally, this project will study how these variants respond to NMDAR modulators with the
goal of rescuing their hypofunction. The approaches leveraged here may serve to study other GRIN1 variants to
expand our understanding of NMDARs in health and disease and may help with informing and developing
individual patient treatments depending on the variant they carry.

Public health relevance
PROJECT NARRATIVE This project will characterize pathological variants in the GRIN1 gene from a molecular to synaptic level to increase our understanding of how N-methyl-D-aspartate receptor (NMDAR) activity contributes to health and disease states. It will delineate the biophysical properties of receptors containing the GluN1 Y647C and Y647S variants, as well as investigate pharmacological rescue with positive allosteric modulators in cultured cells and brain slices. Results from this project will inform us about effects on receptor unitary conductance and gating kinetics, whole cell current amplitude and time course, and effects on excitatory and inhibitory synaptic transmission, which will further reveal the relationship between NMDAR signaling and brain function.